Research Supplements to Promote Diversity in Health-Related Research

Diversity on science teams has been shown to increase research productivity and creativity yet the scientific
workforce lacks sufficient diversity. A range of approaches to diversifying the workforce have been initiated,
such as the BUILD and NRMN efforts, however we still lack scientific evidence as to which approaches work
most effectively, with whom, and for what duration. Going forward, we need both new methods for diversifying
the workforce and better ways to assess their effectiveness. This study seeks to test an intervention (Career
Education and Enhancement for research Diversity (CEED)) designed for postdocs and junior faculty who are
underrepresented in health-related sciences on a national basis. CEED aims to improve the Psychological
Capital of underrepresented trainees by increasing their hope, efficacy, resilience, and optimism. These skills
have repeatedly been shown to impact attitudes and performance. We propose a cluster randomized
controlled trial to test the CEED intervention with 26 institutions. We will standardize the intervention so that it
can be implemented consistently across the treatment sites. Near-peer mentors at the treatment sites will
receive career coaching and mentor training so that they can deliver the intervention more effectively. We will
follow participants for two years to study the impact of CEED. We will also study the factors that contribute to
the participants success by engaging in qualitative research using participant interviews. Finally, when the trial
is concluded, we will disseminate the intervention to the wait-list controls as well as other institutions for a
broad dissemination. Our work aims to improve the culture for postdocs, fellows, and junior faculty who are
underrepresented (UR) in the biomedical research workforce using near-peer and peer mentoring with a 12-
month program that has been successful at retaining UR in academia and in research careers. By training
near-peer mentors to offer the intervention, we empower them as role models. Additionally, by testing the
effects of CEED on Psychological Capital through a rigorous experimental design, we will be able to identify a
potential mechanism through which CEED works.
The Building Up study will support diversifying the workforce with diversity supplements at all stages of
education. Taylor Mathis is currently sophomore (undergraduate) in Statistics at the University of Pittsburgh
Honors College. She will work with the Building Up study by participating in qualitative interview coding and
analysis and will conduct an associated literature review. These are areas that Ms Mathis will not receive
instruction in with her current training program and are important for understanding how qualitative research
efforts contribute to scientific research. This experience will be a significant asset to Ms. Mathis as she
prepares her application for the MPH program in Epidemiology.

Public health relevance
Project Narrative In the Building Up study, we are conducting a cluster randomized trial to test an intervention for people who are underrepresented in health-related science to improve their Psychological Capital, which will improve their productivity and hopefully thus improve their retention within the scientific workforce. As part of the evaluation of participant experience in the trial interventions, we are conducting interviews with 100 participants (50 from the Building Up intervention, and 50 from a control program) in order to more fully understand participant experience and their perceptions of how the programs benefited them and/or could have been improved, thus improving future iterations of the intervention. The proposed supplement will involve Taylor Mathis in the analysis of these interviews, allowing her to follow up on themes identified in the interviews with relevant literature reviews, thus greatly enriching the original analysis plan.